Age in dengue antibody response and risk after primary natural infection

PROJECT SUMMARY/ABSTRACT
Dengue is the most prevalent vector-borne virus plaguing our world. In 2010, there were an estimated 390
million infections worldwide, 25% of which were symptomatic. The pathogenesis of dengue is complex
because of the existence of four serotypes. Infection with one serotype protects the individual against future
infections of the same serotype, but subsequent infection with a different serotype increases the risk of
symptomatic disease, which includes potentially life-threatening dengue hemorrhagic fever and dengue shock
syndrome. In endemic countries, children are most at risk of infection and disease. An immunizing vaccine is
crucial for population protection but large trials of live-attenuated vaccine in children show that younger age is
associated with future infection and severe disease independent of other variables. Vaccination is a correlate
to natural infection, where in previously unexposed individuals, antibodies that cross-react to many serotypes
protect against multiple dengue serotypes but are short-lived. Long-lasting protection most likely comes from a
small fraction of durable antibodies that are specific to one dengue serotype. What determines the production
of these type-specific antibodies and the viral epitopes that they target is not well understood. Immunologic
studies incorporating longitudinal observational data are needed to understand protective antibody
responses after primary natural dengue infection in children.
This study will address relationships between age, antibody quality, and dengue infection or disease. The
proposed research will utilize previously collected data and sera from an ongoing longitudinal observational
study, the Pediatric Dengue Cohort Study in Managua, Nicaragua. Using state-of-the-art recombinant viral
techniques and epidemiologic methods in this one-of-a-kind dataset, the proposal aims to 1) compare how
epitopes targeted by antibodies vary in younger and older children with known dengue serotype 2
infection and 2) assess the risk of dengue reinfection in younger and older children with prior natural
dengue infection. The results will establish the variation in antibody specificity and avidity in younger and
older children and inform future policy decisions regarding vaccination against dengue virus in this population
and possibly other Latin American countries.
Through the completion of these research aims the trainee will gain a unique set of skills in advanced
epidemiologic methods, virology, and immunology research, including analysis and interpretation of complex
immunologic and longitudinal data. Expert mentors in virology, immunology, and epidemiology will support the
trainee’s successful completion of the proposed research, associated training plan, and MD/PhD degree at the
University of North Carolina at Chapel Hill. This F30 fellowship will critically aid the applicant’s development as
a future interdisciplinary physician-scientist practicing at the intersection of virology, immunology, and
infectious disease epidemiology.

Public health relevance
PROJECT NARRATIVE Live-attenuated vaccines against dengue have struggled to achieve high efficacy and safety in children without previous dengue infection and in children under 9 years old. We do not yet know the immunologic determinants of protection in natural dengue infections, nor do we understand how age impacts the development of neutralizing antibodies in previously uninfected children. The findings of this study on infection risk and antibody targets in younger and older children, controlling for prior dengue infection, will inform future vaccine development and improve vaccine safety analyses.